Analysis of Olfactory Dysfunction for Early Diagnosis of Parkinson's Disease

More than one million Americans suffer from Parkinson’s disease (PD), of whom at least 80,000 are
Veterans. Although PD is currently diagnosed on the basis of motor signs, these manifestations are preceded
by a period that lasts several years to decades, in which neurodegeneration spreads to many brain regions. The
earlier we can detect PD, the longer the window of opportunity to treat it before disabling symptoms appear.
Learning how to prevent disabling symptoms will require identifying markers that not only enable accurate early
diagnosis, but also enhance understanding of disease pathogenesis, paving the way for the development of
early intervention with disease-modifying drugs. Sense of smell is the first casualty of PD. Although the possibility
of using olfaction as a biomarker for PD has garnered increased interest in recent years, it will only be possible
once we have achieved a better understanding of the mechanisms of this olfactory loss and its cause-and-effect
relationship to -synuclein pathology, a hallmark of PD.
Our over-arching hypothesis is that olfactory damage in PD is an early event directly linked to upstream -
synuclein toxicity and based on specific neuroanatomical changes with measurable functional impact. By
capitalizing on a well-established transgenic mouse model overexpressing human wild-type -synuclein in the
brain, we showed in our current VAMR a causative role for -synuclein pathology in cerebral blood flow (CBF)
deficit and olfactory dysfunction in PD. To develop further the potential of olfactory dysfunction as a multi-faceted
biomarker, we seek in-depth understanding of the role of CBF alterations in olfactory dysfunction, including its
mechanistic relationship to -synuclein pathology. Using the -synuclein transgenic mouse, we will assess how
progressive accumulation of -synuclein leads to disruption of the counter-regulatory mechanism between the
brain renin-angiotensin system (RAS) and dopamine, leading to abnormal local upregulation of the RAS and
deficits in CBF. In addition, we will elucidate the role of progressive -synuclein accumulation in metabolic
dysregulation, altered energy homeostasis, mitochondrial dysfunction, oxidative stress, and neuroinflammation,
as well as the relationships of these processes to CBF deficit and olfactory dysfunction. Our approach features
immunohistochemistry, biochemistry, behavioral assessments, and advanced neuroimaging modalities (arterial
spin-labeling MRI, diffusion tensor imaging, and fMRI) that are readily translatable to patients.
Focusing on progressive -synucleinopathy in transgenic mice at 4, 9, and 16 months of age, representing
prodromal, preclinical, and clinical stages of PD, respectively, our specific objectives are:
1. To elucidate the relationship between abnormal-synuclein aggregation and CBF deficit in PD-related
olfactory dysfunction;
2. To understand the mechanism of -synuclein overexpression-induced oxidative stress and
neuroinflammation, leading to CBF deficit and impaired sense of smell; and
3. To explore the relationship between abnormal -synuclein aggregation and the dysregulation of energy
homeostasis in PD-related olfactory dysfunction.
These studies are significant, as the results will substantially enhance understanding of the mechanistic
relationships among olfactory loss, CBF deficit, and -synucleinopathy in PD, thereby accelerating efforts to
move much-needed early diagnosis to clinical reality. Our approaches are innovative since they exploit cutting-
edge non-invasive multimodal MRI in a fashion that could be readily translated to the clinic. Owing to our
investigative team’s in-depth expertise in olfaction, PD, neurodegeneration, oxidative stress, inflammation,
neurobehavioral testing, and advanced imaging technologies, along with the unique advantage of an 11.7 Tesla
magnet for high-resolution MRI, the proposed studies have high feasibility.

Public health relevance
Parkinson’s disease (PD) is a major cause of morbidity and mortality in the Veteran population, comprising an increasingly prevalent neurodegenerative disease with profound motor, cognitive, and behavioral dysfunction. More than a million Americans suffer from PD, of whom more than 80,000 are Veterans, and about 50,000 new cases are diagnosed annually. The burden of PD is especially heavy in the Veteran population, due in part to the aging demographic – age is the best documented risk factor – as well as the risks of traumatic brain injury and exposure to environmental neurotoxins in military settings. The total US economic burden of PD – currently $52B annually – is expected to skyrocket as almost eight million baby boomers, including many Vietnam era Veterans, have recently turned 60, the age at which PD prevalence begins to increase sharply. Identification of early diagnostic biomarkers, as we propose to do in this application, will provide the best opportunity for effective early intervention to treat the disease before disabling symptoms appear.